Pittsburgh Biomedical Informatics Training Program

Since 1988, the Pittsburgh Biomedical Informatics Training Program (BMITP) has provided advanced training in the application of computing to challenging problems in biomedicine. In addition to our long history, our program is notable for continuous evolution of our programs, a highly collaborative research environment, and strong institutional support from the University of Pittsburgh and the University of Pittsburgh Medical Center (UPMC). BMITP is housed in the Department of Biomedical Informatics (DBMI) in Pitt’s School of Medicine. DBMI provides, space, equipment, and financial support for training program administration, faculty, and trainees. BMITP’s core faculty of 39 members, including the 19 faculty members with primary appointments in DBMI. BMITP is led by the Program Director and Associate Director, with the help of an experienced program administrator and a leadership group of faculty co-directors. The Pittsburgh Biomedical Informatics Training Program offers research training in translational bioinformatics, health care/clinical informatics, imaging informatics, clinical research informatics, and public health informatics. Trainees seek MS or PhD degrees in either Biomedical Informatics or through the Biomedical Informatics Track of the Intelligent Systems Program, housed in Pitt’s School of Computing and Information. We also train MD/PhD students through the University of Pittsburgh’s Medical Scientist Training Program. Postdoctoral trainees undertake advanced research, with the goal of developing research programs and funding applications that will support their transition to independence. A broad variety of courses at both the University of Pittsburgh and Carnegie-Mellon University are available to all trainees. During the past five years, we have revised our curriculum, our admissions processes, and our preliminary and comprehensive exams. We have also expanded our data science offerings. Our plans for the next five years include further strengthening of our evaluation efforts, enhancing mentoring, expanding the range of internship opportunities available to trainees, and using our streamlined evaluations to help trainees productively reach milestones and complete their degrees in a timely manner. We have a strong track record of training successful biomedical informatics researchers, many of whom have gone on to be leaders in the field. Trainees in our programs publish research articles in high-impact journals, win national awards for their research, successfully compete for NIH funding, and secure research positions in academia, industry, and government.

Public health relevance
The mission of the Pittsburgh Biomedical Informatics Training Program is to prepare trainees to become outstanding leaders in biomedical informatics research, education, and practice, through world-class training with a focus on artificial intelligence and computing methods for biomedical problems. This proposed renewal will support upcoming predoctoral, postdoctoral, and short-term trainees in translational bioinformatics, clinical informatics, imaging information, clinical research informatics, and public health informatics. Enhanced plans for recruitment, outreach, and evaluation will strengthen our program.